Research and Mentoring in the Clinical Epidemiology and Health Disparities of Cardiovascular Diseases and Hypertension

PROJECT SUMMARY
Cardiovascular disease affects nearly half of all American adults. Achieving cardiovascular health is
associated with lower mortality and morbidity, but modifying and adhering to health behaviors such as diet
and other healthy lifestyle factors remain challenges to achieving it. Additionally, there are historically
marginalized communities of individuals who suffer the greatest burdens of cardiovascular disease and are in
urgent need of effective, pragmatic, and culturally appropriate interventions. To address these issues, we
must train the next generation of patient-oriented investigators who are rigorously mentored in cardiovascular
disease epidemiology, health equity, health disparities, and translational research methods; and who are
committed to doing the work with cultural humility and a global perspective. This proposal focuses on
necessary steps for developing a novel comprehensive and structured mentorship and research program that
will support mentees. This K24 award will provide protected time for Dr. Cheryl Anderson, a mid-career
clinical investigator who has her own independent peer- reviewed research support to recruit and mentor a
diverse group of trainees in clinical cardiovascular epidemiology and health equity. Dr. Anderson proposes to
facilitate a training environment that is rigorous, supportive, creative, and collaborative where mentees
develop their research in a manner that capitalizes on her expertise and preserves their independent lines of
research. The research program she proposes will build on her current grants and support her ability to
pursue developing new skills in health equity and global policy and strategy. More specifically, the award will
support the building of two new areas of research: 1) integration of the science of global policy and strategy
into multilevel interventions to improve cardiovascular health, and 2) development of skills to train others to be
effective change agents to disrupt health inequities via the creation of an “Advocacy Laboratory.” The
environment for this K24 is the University of California San Diego, a world-class institution with extensive
resources to support research that is patient-oriented and integrated with research in health equity and global
policy and strategy.

Public health relevance
PROJECT NARRATIVE The goal of this project is to conduct mentoring and research that is patient oriented, sustainable, and focused on the clinical epidemiology and health disparities of cardiovascular diseases and hypertension. Dr. Anderson will leverage a strong track record of successful mentoring and research to recruit and train a diverse group of early career scientists, and strengthen her research portfolio for greater impact on global policy and advocacy.